Differential control of 2-AG’s activity at CB1R by ABHD6 and MAGL

Summary
The most abundant endocannabinoid (eCB) in brain, 2-arachidonoyl glycerol (2-AG), is inactivated by two
enzymes: monoacylglycerol lipase (MAGL) and α/β hydrolase domain-contain 6 (ABHD6) that differ in their
hydrolyzing activities and subcellular localization (presynaptic and postsynaptic, respectively). Accordingly,
selective inhibition of each enzyme results in different spatiotemporal enhancement of 2-AG-CB1R signaling in
the brain, and potentially synergistic therapeutic benefits.
We recently gathered results showing that stimulated increase in 2-AG production is reliably measured using
GRABeCB2.0, a recently developed 2-AG sensor. Remarkably, metabotropic receptor mediated increase in 2-AG
is controlled by ABHD6, whereas ionotropic receptor-dependent increase in 2-AG is not controlled by ABHD6.
These results raise the question of how MAGL controls stimulation-dependent 2-AG production?
Demonstrating that receptor-dependent increases in 2-AG production and activity at CB1R signaling are
differentially controlled by ABHD6 and MAGL would provide an additional level of mechanistic distinction
between these eCB-hydrolyzing enzymes. To increase our understanding of the respective roles of ABHD6 and
MAGL in controlling 2-AG-CB1R signaling in brain, we initiated an effort and have now successfully validated the
GRABeCB2.0 pharmacological profile in neural cells in culture and identified several stimuli that increase 2-AG
production. Based on this premise, we propose to address the following two questions in mouse neurons in
primary culture and striatal slices using live-cell fluorescence microscopy, two-photon microscopy and
electrophysiology:
Aim 1: Which stimuli increase 2-AG production and GRABeCB2.0 signal in neurons?
Aim 2: How do ABHD6 and MAGL differentially control stimuli-dependent increases in 2-AG-CB1R
signaling in neurons?
Completion of the work outlined in this new R21 grant proposal will provide a comprehensive understanding of
the respective role of ABHD6 and MAGL in controlling 2-AG-CB1R signaling in the brain. Our long-term goal is
to increase our understanding of the molecular, cellular, and system’s level differences by which ABHD6 and
MAGL control eCB signaling in brain, a body of work that will help develop novel therapeutics with reduced
potential for abuse and adverse effects produced by classic cannabinoid agonists.

Public health relevance
Project Narrative Small molecules that modulate endocannabinoid (eCB) signaling in brain represent promising therapeutics for the treatment of neurological diseases, including drug addiction. Here we will study how the two eCB-hydrolyzing enzymes, α/β hydrolase domain-contain 6 (ABHD6) and monoacylglycerol lipase (MAGL), differentially control the stimulated production of 2-arachidonoyl glycerol (2-AG, a major eCB in brain), and its ensuing activity at cannabinoid 1 receptors (CB1R) using a genetically encoded biosensor (GRABeCB2.0) that detects real-time changes in 2-AG levels. This research will provide a comprehensive understanding of the mechanistic differences by which ABHD6 and MAGL control 2-AG-CB1R signaling in brain, a body of work that will help the development of novel therapeutics.